SIRT6 and vascular endothelial homeostasis

The major goal of the project is to elucidate the molecular mechanisms underlying cardiac microvascular fatty
acid transport dysfunctions and its involvement in heart failure with preserved ejection fraction (HFpEF) under
diabetic conditions. Diabetes mellitus, one of the major leading chronic morbidities worldwide, is continually
increasing with a high prevalence in the United States and throughout the world. Cardiovascular complications
are mainly responsible for the high morbidity and mortality in people with diabetes. Type 2 diabetes (T2D) is one
of key risk factors for the development of HFpEF, and the prevalence of HFpEF is rising in parallel with global
surging of T2D. However, the molecular mechanisms linking diabetes to HFpEF are poorly understood, and
currently there are no effective treatments available for HFpEF. Endothelium, a cell layer lining of blood vessels,
is an independent organ that functions as a barrier for the nutrient shuttling. The neglected role of endothelium
in controlling the metabolic homeostasis is beginning to evolve. However, the role of coronary microvascular
endothelial fatty acid shuttling in diabetic heart and the underlying molecular mechanisms remain elusive. Sirtuin
6 (SIRT6), a well-recognized longevity gene, regulates genome stabilization, DNA repair, inflammation and
metabolic homoeostasis. SIRT6 is a histone deacetylase that targets the acetylation of histone 3 lysine 9, an
epigenetic marker for active gene transcription. Recent studies indicate that SIRT6 deficiency is associated with
metabolic disease, and SIRT6 has been proposed as a potential therapeutic candidate fighting the metabolic
syndrome epidemic. In parallel, emerging evidence from our group suggests that SIRT6 plays a crucial role in
regulation of cardiac endothelial homeostasis. Specifically, we have recently found that SIRT6 modulates
coronary microvascular endothelial fatty acid transport and cardiac lipid metabolism under the nondiabetic and
diabetic conditions, which is implicated in the pathogenesis of T2D-induced HFpEF. As such we propose that an
alternation of SIRT6 expression and function in coronary microvascular endothelial cells under diabetic
conditions could cause cardiac microvascular endothelial fatty acid transport abnormality and cardiac metabolic
disarrangement, which may cause diabetes-associated diastolic dysfunction. We will use the combination of in
vitro and in vivo experiments to test this novel hypothesis. Results from proposed studies would help to
understand molecular basis of endothelial FA transport, and facilitate the development of new therapeutic
approaches, such as enhancing SIRT6 expression and activity, to limit diabetes-associated HFpEF, a deadly
disease without any effective therapy.

Public health relevance
Public Health Relevance Diabetes mellitus, one of the major leading chronic morbidities worldwide, is continually increasing with a high prevalence in the United States and throughout the world. Cardiovascular complications are mainly responsible for the high morbidity and mortality in people with diabetes. The proposed studies will significantly increase our understanding of molecular mechanisms underlying diabetes-associated coronary endothelial dysfunction and abnormal lipid transport and therefore provide the basis to develop new therapeutic strategies for the treatment of diabetes-associate cardiovascular diseases.